Mechanism and Inhibition of Protein Arginine Methylation

Abstract We are submitting an administrative supplement request to support an undergraduate student Julie Nguyen to conduct summer research within the scope of the original project. Ms Nguyen is currently a third year undergraduate student at UGA majored in pharmaceutical science, and this moment is the prime time for her to engage in laboratory research experiences. Ms Nguyen has a demonstrated interest in and desire to pursue research in health-related sciences, especially drug discovery and pharmaceutical science. The PI’s R01 project regarding the mechanism and inhibition of protein arginine methyltransferases (PRMTs) offers an ideal platform for the student to participate in the research area well aligned with her science passion. The supplement support will impact on and add a positive value to the undergraduate’s career development experience.

Public health relevance
Narrative An administrative supplement is requested to support the undergraduate student Julie Nguyen to conduct work in drug discovery and pharmaceutical science. The effort will assist our educational mission to train next generation students in the biomedical research career.